Chemical Grammar of Accumulation in Drug Resistant Acinetobacter baumannii with Subcellular Resolution

Multidrug-resistant (MDR)
PROJECT SUMMARY
Acinetobacter baumannii (A. baumannii) is recognized as one of the most urgent
global health threats due to its high resistance to nearly all available antibiotics. The rising prevalence of
infections caused by this pathogen severely limits treatment options and poses a significant challenge to modern
healthcare systems. The primary obstacle in treating
A. baumannii infections lies in the bacterium’s unique outer
membrane, which acts as a formidable barrier, preventing many antibiotics from reaching their intracellular
targets. Despite the critical need for new antibiotics and adjuvants that can overcome this barrier, our
understanding of the molecular rules that govern antibiotic accumulation into A. baumannii remains limited.
This project aims to address this gap by developing and applying innovative high-throughput screening platforms
designed to measure the accumulation of small molecules in
A. baumannii with subcellular resolution. Our
approach leverages two novel platforms: PAC-MAN (Peptidoglycan Accessibility Click-Mediated AssessmeNt)
and CAC-MAN (Cytoplasmic Accessibility Click-Mediated AssessmeNt). These platforms will enable the rapid
and detailed analysis of a large library of molecules across multiple
A. baumannii strains, including drug-resistant
variants. The data generated will be used to identify the chemical properties that facilitate molecular entry and
accumulation within these bacterial cells.
Additionally, we will conduct a large-scale screen to discover new outer membrane disruptors that can synergize
with existing antibiotics, enhancing their efficacy against MDR
A. baumannii. By integrating these findings with
advanced machine learning algorithms, we aim to establish a comprehensive framework for predicting molecular
permeability in
A. baumannii. The results of this research will provide critical insights into the development of
next-generation antibiotics and adjuvants, addressing a pressing need in the fight against antibiotic resistance
and improving outcomes for patients suffering from these difficult-to-treat infections.

Public health relevance
PROJECT NARRATIVE The alarming rise of multidrug-resistant (MDR) Acinetobacter baumannii (A. baumannii) infections presents a significant global health threat, as current antibiotics are increasingly ineffective against these pathogens. This project seeks to advance the discovery and development of new antibiotics and adjuvants by establishing a comprehensive understanding of the chemical properties that enable small molecules to penetrate the outer membrane and accumulate within A. baumannii cells. By employing innovative high-throughput screening platforms and machine learning algorithms, this research will provide critical insights into molecular permeability, identify new outer membrane disruptors, and ultimately inform the creation of more effective treatments for MDR A. baumannii infections, thereby addressing a crucial unmet need in modern medicine.